Safer Universities Project

Under this agreement with the Centers for Disease Control and Prevention, the NIAAA agrees to provide support for the Safer Universities project which will develop, implement and evaluate a marketing strategy to encourage the widespread adoption of a comprehensive, community-based environmental prevention program on college drinking.